Molecular Construct and Packaging Core

Molecular Construct and Packaging: is a new core directed by Marie Burns to provide molecular construct and viroid particle production, focused on producing tools needed for optogenetics and perturbation of gene expression in vision research. To facilitate the development of this core, the Dean of the Medical School has provided salary support for a highly experienced professional staff member (50% FTE for 1 year). 11 R01i investigators and two new faculty are anticipated to be moderate to extensive users.